Vet-LIRN Network Capacity- Builiding Project

Abstract: The focus of this proposal is to seek funding for the Frederick Animal Health Laboratory (FAHL) to expand the capability to support the mission of Vet-LIRN (Veterinary Laboratory Investigation and Response Network), though development of high capacity PCR testing using an ABI 7500F for detection of Listeria, Salmonella, or E. coli in animal food/feed. FAHL is an ISO 17025 Accredited diagnostic laboratory and is part of the Maryland Department of Agriculture. FAHL has the staff, equipment, technology, and management system to be able to provide critical resources that will benefit and support Vet-LIRN.

Public health relevance
Project Narrative: Recent years have seen an increase in the threats to the food safety and security of both human and animal food supplies. In the proposed cooperative agreement Frederick Animal Health Laboratory will partner with the Veterinary Laboratory Investigation and Response Network (Vet- LIRN) to provide increased resources for the investigation of and response to animal food related illnesses through the development of high capacity PCR testing using an ABI 7500F for detection of Listeria, Salmonella, or E. coli in animal food and feed.